Investigating Novel HIV Reservoirs in the Pulmonary Vasculature

PROJECT SUMMARY
Infections with Human Immunodeficiency Virus (HIV) remain a major global public health concern. The HIV
reservoirs are a leading reason for which HIV infection remains without a cure. HIV integrates its viral DNA into
the host cell DNA. Cell activation leads to transcription of archived viral information, which can refuel viral
replication even in the presence of antiretroviral therapy (ART). This may be problematic when cellular reservoirs
of HIV involve cell types that are in continuous functional activation. Research conducted by others and us have
shown that pvSMC are susceptible to HIV infection. In addition, people living with HIV (PLWH) are more prone
to comorbidities that involve chronic vascular constriction. Our preliminary studies suggest that pulmonary
arterial smooth muscle cells are susceptible to HIV infection, sustain the infection during ART-induced viral
suppression, and are capable to release infectious viruses that can infect bystander T cells. Our preliminary
findings have significant importance because identifying and eliminating HIV reservoirs such as pvSMC is critical
to the success of global efforts to cure HIV. The fact that PLWH are more prone to pulmonary vasoconstrictive
diseases implies that the persistent cell activation and vasoconstriction of pvSMC are likely to provide
transcriptionally active HIV leading to reseeding of reservoirs. The pulmonary vasculature is heavily overlooked
as an important source of HIV, leading to a significant gap in the literature about non-immune cell sources such
as pvSMC as HIV reservoirs. Herein, we propose to determine the ability of pvSMC to support chronic HIV
infection and their ability to spread HIV to bystander immune cells in the presence of ART. We also propose to
investigate the cellular mechanisms for the resiliency of pvSMC to the cytopathic effects of HIV. This work should
provide new insights into the potential of pulmonary vascular as SMC as reservoirs in the era of advanced ART.
Knowing the characteristics of pvSMC as HIV reservoirs is imperative to further strategize for the effective
eradication of a previously unappreciated HIV reservoir.

Public health relevance
NARRATIVE The presence of Human Immunodeficiency Virus (HIV) in the cells of the infected people limits the development of an effective cure to this infection. These cells or organs where the virus persists are called “HIV reservoirs” and scientists are still working to keep discovering new HIV reservoirs that may need study. We propose experiments to investigate a cell type that is in the blood vessels of the lungs as potential cells acting as viral reservoirs.